MECHANISMS IN REGULATING DNA DAMAGE-INDUCED GENES IN A UMUC-DEFICIENT BACTERIUM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The long term goal of this research is to understand the mechanisms by which cells respond to DNA damage. The link between DNA damage and human health is well-established: the inability to correctly repair damaged DNA can result in various forms of colon, breast, and ovarian cancers in humans. The existence of similar, extensive DNA damage sensing and repair mechanisms in organisms ranging from humans to bacteria demonstrates this central role of DNA integrity. In the typical bacterial SOS response pathway, after DNA damage, the UmuD protein self-cleaves, and then acts with its partner, UmuC, to function as a translesion synthesis DNA polymerase.